PA-20-072 Stakeholder-Partnered Implementation Research and Innovation Translation (SPIRIT) Program: Vulnerable Populations Cared for by Learning Health Systems During the COVID-19 Pandemic

PROJECT SUMMARY/ABSTRACT As a collaboration among UCLA, Kaiser Permanente Southern California, the VA Greater Los Angeles Healthcare System, and the LA County Department of Health Services, the AHRQ-PCORI K12 program, Stakeholder-Partnered Implementation Research and Innovation Translation (SPIRIT), is designed to prepare outstanding postdoctoral scholars for academic research careers focused on rapid and sustainable uptake of new scientific discoveries and innovations that improve the design, delivery, and outcomes of care for chronic diseases at the individual, population, and health care system levels. This supplement to the SPIRIT K12 Program leverages existing K12 Scholar projects and expands the specific aims of their ongoing research to develop high-impact new knowledge concerning COVID-19 and the ongoing pandemic. Three of our current K12 scholars are proposing supplemental work that address health issues that have arisen due to COVID-19. These projects address how different vulnerable populations with health care needs, including adults with diabetes, children with autism spectrum disorder, and Veterans with severe mental illness, are managing during the stay-at-home orders during the COVID-19 pandemic and evaluate their experiences with one solution for health care provision, telehealth, during stay-at-home orders.

Public health relevance
PROJECT NARRATIVE Through mentored research career development of the next generation of interdisciplinary team members, leaders, and innovators in dissemination and implementation science and learning health systems, the Stakeholder-Partnered Implementation Research and Innovation Translation (SPIRIT) K12 Program will advance our knowledge of delivery and implementation strategies for proven interventions in real-world practice and community settings. This supplement to the SPIRIT K12 Program leverages existing K12 Scholar projects and expands the specific aims of their ongoing research to develop high-impact new knowledge concerning COVID-19 and the ongoing pandemic.